The role structural discrimination on depression, sleep, cardiovascular disease, and cognitive decline

PROJECT SUMMARY
This application for a Research Supplement to Promote Diversity in Health-Related Research (PA-21-071)
proposes a research and career development plan to develop the independence of Dr. Paris Adkins-Jackson
through a study titled, “The role of structural discrimination on depression, sleep, cardiovascular disease, and
cognitive decline” for the award period of 10/1/21-9/30/23. The parent grant, “Reducing racial disparities in
Alzheimer’s Disease and related dementias: Addressing structural discrimination and resilience”
(DP1AG069874). The parent grant is a sequential mixed methods study to develop a measure of structural
discrimination and then determine the influence of structural discrimination on cognitive decline in the United
States (US). The study draws expertise from Black community members to elucidate how 9 domains of
structural discrimination impact the lives of Black older adults. These domains include (1) education, (2)
employment, (3) healthcare, (4) environment, (5) neighborhoods, (6) policing, (7) media and marketing, (8)
civics, and (9) income, credit, and wealth. The proposed supplement study is a secondary data analysis
examining the influence of structural discrimination on known relationships between Alzheimer’s disease (AD)-
related cognitive decline and co-morbidities like depression, sleep deprivation, and cardiovascular disease.
This study will test the validity of the parent award’s 9-domain measure of structural discrimination in two large
aging datasets: National Health and Aging Study (NHATS) and Health and Retirement Study (HRS).
Additionally, this study will estimate the influence of the nine domains of structural discrimination on the
previously established relationships of AD-cognitive decline with depression, sleep deprivation, and
cardiovascular disease. The proposed diversity supplement will significantly contribute to the understanding of
the role of structural discrimination on AD racial disparities by delineating the effect of structural discrimination
on AD and a few known risk factors and provide mentorship for developing a K award and publication profile in
structural discrimination and cognition.

Public health relevance
NARRATIVE The experiences across a life time accumulate for older adults. These experiences are often structured according to their race, such that African American older adults have often lived through different experiences of neighborhood, income, healthcare and other important domains. This proposed supplement will allow a strong junior investigator to research the association of impact of these domains with the cognition of older African Americans.